Contributions of aberrant synaptic protein monoaminylation to opiate use disorder

PROJECT SUMMARY
Opiate use, dependence and addiction represent enduring public health issues, resulting in substantial financial
and societal health burdens, as well as increasing numbers of overdoses. Drug addiction is characterized as a
chronic, relapsing disease. However, to date, there remains insufficient data examining the molecular
mechanisms underlying persistent opiate-induced neurobiological changes, which has led to a scarcity of
effective therapies and interventions to treat and prevent relapse.
Drug addiction has long been thought of as a disorder of dopamine (DA) signaling. However, therapeutic
interventions targeting receptor mediated DA neurotransmission have not yet resulted in fully efficacious
treatments. Therefore, an overarching goal of our laboratories – and the focus of this application – has been to
investigate novel, non-canonical actions of DA involved in mediating addiction phenotypes. Our laboratory
recently identified a novel signaling moiety for DA in brain, termed dopaminylation (dop), whereby DA acts as
a donor source for the establishment of post-translational modifications (PTM) on substrate proteins (e.g.,
histone H3) via transamidation by the Transglutaminase 2 (TGM2) enzyme. In more recent efforts by our lab to
unbiasedly identify additional substrates of these PTMs (focused now on synaptic proteins in nucleus
accumbens/NAc, a key brain reward region), we developed a novel chemical tagging approach that, when
coupled to mass spectrometry, allowed for the discovery of hundreds of dopaminylated proteins in brain, both in
the context of normal neural function and in response to aberrant dopamine signaling following chronic heroin
self-administration (SA) in rats. Among them, gCaMKII: 1) was found to be robustly dopaminylated at only a
single amino acid residue located within its autoinhibitory helix [glutamine (Q)285], a site that exists only two
amino acids away from a critical threonine (T) residue (287), which when phosphorylated directs Calmodulin
(CaM) sequestration; 2) is upregulated in its dopaminylation following heroin SA, both during acute and
prolonged abstinence, but not in response to natural rewards; and 3) represents a critical substrate involved in
mediating long range signals from the synapse to nucleus in brain, ultimately promoting CREB activation and
neuronal plasticity. Thus, this dopaminylation event on gCaMKII may represent a critical convergent mechanism
linking altered dopaminergic signaling in response to heroin to CREB mediated transcriptional abnormalities. As
such, we hypothesize that gCaMKIIQ285dop may play a direct role in mediating heroin relapse via aberrant
modulation of CREB signaling in NAc. In Aim 1, we will fully characterize gCaMKIIQ285dop’s temporal effects
on drug taking vs. relapse vulnerability in the context of heroin SA. In Aim 2, we will explore gCaMKIIQ285dop’s
effects on CREB signaling/transcription following heroin SA, events that may precipitate relapse vulnerability. In
Aim 3, we will investigate roles for gCaMKIIQ285dop mediated CREB signaling/transcription in D1 vs. D2
dopamine receptor-expressing MSNs during abstinence from heroin SA in the regulation of relapse behaviors.

Public health relevance
PROJECT NARRATIVE Opiate addiction is a chronic, relapsing disorder that affects millions of individuals worldwide; however, few effective treatment options for opioid abuse and addiction exist. Here, employing a unique combination of behavioral, molecular, epigenomic and viral gene therapy-based approaches, we will assess the impact of chronic heroin self-administration in rats (a well characterized rodent model of volitional opioid use/abuse) on molecular abnormalities in brain – namely aberrant synaptic protein dopaminylation states – that result in heightened propensities for relapse following periods of drug withdrawal. This proposal thus aims to transformatively integrate expertise from multiple disciplines (e.g., molecular neuroscience, epigenomics and behavioral pharmacology) to fully characterize novel synaptic to nuclear signaling cascades contributing to persistent opioid addiction, with the hopes that such information will aid in the future development of more effective therapeutic interventions.